Individual-level determinants and clinical outcomes of head impact exposure in youth hockey

Project Summary/Abstract:
Ice hockey is a collision/contact sport with a high rate of injury. Body checking, where an athlete intentionally
collides with an opponent to gain possession of the puck is a critical component of play in boys’ and men’s
hockey. Although body checking is not allowed in women’s and girls’ hockey, it is still considered a contact sport;
male and female hockey athletes share comparable rates of concussion. Recent evidence suggests that
exposure to subconcussive head impacts, even in the absence of clinically-diagnosed concussion is sufficient to
cause alterations in brain microstructure and cognitive function. Assessments of postural control have been used
to aid diagnosis of concussion, and evidence suggest that such assessments are sensitive enough to detect
subclinical injury. To date, no studies have evaluated individual-level performance (athlete skill) as a determinant
of head impact exposure. Future interventions could target skill development in an effort to improve sport safety,
particularly at the youth level. However, accurate quantification of head impact exposure and the relationship it
shares with individual performance metrics and clinical postural control deficits is necessary before interventions
can be implemented. The objective of this study is to use a mouthpiece-sensor for measurement of head impact
exposure in male and female youth hockey athletes and evaluate the relationships between cumulative
exposure, individual performance metrics, and postural control deficits. The study team identified in this proposal
has extensive history in quantifying head impact exposure in youth sports and in evaluating clinical outcomes. A
well-developed research and mentorship plan has been prepared for the successful completion of the following
aims. In Aim 1, 32 boys’ and 32 girls’ youth hockey athletes will complete a pre- and post-season assessment
of ice hockey performance. Youth athletes will be instrumented with a custom mouthpiece sensor to wear during
the season. All on-ice sessions will be recorded and reviewed to identify characteristics of head impacts. We will
quantify impact frequency and magnitude for each impact. In Aim 2, instrumented youth athletes will undergo a
pre- and post-season postural control assessment. Changes in postural control measures from pre- to post-
season will be evaluated for correlation with on-ice head impact exposure and youth athlete performance metrics.
Successful completion of this research will elucidate previously undescribed relationships between head impact
exposure, youth athlete performance metrics, and postural control deficits. Future intervention studies can utilize
this research to design strategies aimed at improving youth athlete performance to reduce exposure, which in
turn may decrease postural control deficits. This research could ultimately serve as an early advancement
towards policy change that will improve youth hockey safety and mitigate risk of brain injury or functional
impairment.

Public health relevance
Project Narrative: Boys’ and men’s ice hockey is a collision sport, and women’s and girl’s hockey a contact sport with a high rate of injury and exposure to repetitive head impacts. Recent studies have shown that repetitive head impacts sustained in collision and contact sports may be related to brain changes, even in the absence of clinically diagnosed concussion. The proposed F31 award will evaluate youth athlete performance metrics as a potential determinant of head impact exposure, and will use a postural control assessment to measure clinical outcomes of cumulative exposure to head impacts; the didactic, mentor-guided fellowship proposed will prepare the applicant towards a career as an independent investigator utilizing a joint background in neuroscience and injury biomechanics towards improving athlete safety.